HuR/HIF – SIRT1 Signaling Axis in Liver Transplant Rejuvenation

ABSTRACT
Orthotopic liver transplantation (OLT) is the gold standard of care in patients with end-stage liver disease and
those with tumors of hepatic origin. However, the scarcity of donor organs prompted the use of extended criteria
“marginal” livers, which are particularly susceptible to ischemia-reperfusion injury (IRI), which predispose to
acute/chronic rejection, and may require re-transplantation. We have introduced the concept of organ
“rejuvenation”, i.e., conversion of the donor liver from the state of IRI-hypersensitivity to the homeostatic state of
IRI-resistance. We have also proposed that SIRT1 deacetylase serves as a rheostat linking IR-stress with liver
rejuvenation in both, mouse and human OLT. We have recently identified new regulators of hepatic resistance
against warm vs. cold ischemia stress responses, i.e., Human Antigen R (HuR) and Hypoxia-Inducible Factor
(HIF-1α). We have also discovered Ikaros (IKZF1), acts as a macrophage activation marker and exacerbates
liver IRI. Importantly, we also found that preserved hepatocellular function/improved clinical outcomes in human
OLT patients were associated with increased HuR/HIF-1α but depressed Ikaros levels in the liver biopsy
samples. We hypothesize that crosstalk between hepatocyte HuR / HIF-1α and macrophage Ikaros provides a
new means to regulate the adaptation of donor livers to IR-stress and reperfusion-mediated hepatic damage.
Specific Aim 1: Determine mechanisms of hepatocyte HuR / HIF-1α crosstalk with SIRT1 in IRI-OLT.
Hypothesis: Hepatocyte SIRT1 activation, controlled by distinct hypoxia/reoxygenation (H/R) requirements for
HuR (warm H/R) vs. HIF-1α (cold H/R), provide new means to regulate adaptation of donor livers to IR-stress.
1.1: SIRT1 function is dependent on HuR signaling for anti-inflammatory responses in oxidative stress. 1.2:
HuR/HIF-1α signaling in a mouse model of hepatic ischemia is temperature stress-dependent. 1.3: HIF-1α
controls cold-induced IRI-OLT. 1.4: HuR controls warm-induced IRI-OLT.
Specific Aim 2: Delineate mechanisms of macrophage Ikaros crosstalk with SIRT1 in IRI-OLT.
Hypothesis: Macrophage Ikaros signaling exacerbates IRI-OLT by repressing SIRT1 transcription and M2
macrophage polarization. 2.1: Ikaros-SIRT1 myeloid axis influences hepatic HuR/HIF1α hypoxia sensing circuit
in IRI-OLT. 2.2: Macrophage Ikaros signaling depends on SIRT1 transcription for M2 polarization.
Specific Aim 3: Define mechanism of human liver rejuvenation under hypothermic machine preservation.
Hypothesis: Manipulation of HIF-1α / SIRT1 axis during ex-vivo HMP improves hepatocellular function to
rejuvenate human livers declined for transplantation due to preexisting poor quality. 3.1: Pharmacological
stabilizer of HIF-1α protein synergizes with SIRT1 to improve human liver function. 3.2: Preconditioning with
PHD-inhibitor, which activates/stabilizes HIF-1α, synergizes with enhanced SIRT1 signaling to ameliorate
inflammation, promote cytoprotection, and rejuvenate human livers. These experiments are of high relevance to
refine donor liver donation (DBD and DCD) as well as to improve quality/size of the current organ supply.

Public health relevance
PROJECT NARRATIVE The shortage and poor quality of donor organs represent major limitations facing liver transplantation, the gold standard of care in patients with end-stage liver disease and those with tumors of hepatic origin. The goal of this project is to improve long-term liver transplant outcomes as well as “rejuvenating” suboptimal hepatic tissue, and promoting homeostasis via hepatocyte – macrophage cross-regulation. Our findings should facilitate innovative interventions to improve the quality and size of the current organ supply, an absolute imperative for the full realization of success for solid organ transplantation.